SBIR PHASE I - TOPIC 426 - TOOLS AND TECHNOLOGIES FOR VISUALIZING MULTI-SCALE DATA

This work enables the sharing of complex information in the form of an interactive data atlas. The atlas enables researchers to organize large, heterogeneous data into a form that can be easily viewed, explored, analyzed, and disseminated through a web browser, even when the data is distributed across multiple computers and cloud resources. In particular, the atlas is designed to represent biological data across multiple scales, ranging from geographically dispersed population information, through histological sections of tissue, cell segmentations, and genomic information. By combining these data scales into an easy-to-navigate atlas, healthcare researchers will be able to develop new understandings of the development of cancer, and ultimately create new treatment protocols and therapies for the treatment of the disease. The proposed work builds upon existing, proven open source tools to create a new software framework to provide multi-scale semantic zoom, coupled with interactive methods to visualize and process data in selected regions of interest.